Metabolic Imaging Marker for Triple Negative Breast Cancer

? DESCRIPTION (provided by applicant): Some triple negative breast cancers are dependent on utilization of glutamine for survival and proliferation. Glutamine-addictive phenotype provides a potential therapeutic target and may lead to more effective management of triple negative cancers, which currently have few therapeutic options. Considering the heterogeneity in gene expression profile and possibly glutamine utilization in these cancers, a non- invasive imaging marker that would identify the glutamine-avid phenotype is necessary. Based on promising preliminary data from animal studies of a newly developed 18F- labeled glutamine analog for positron emission tomography (PET), this R21 proposal will examine key feasibility issues of this imaging probe. We will determine the nature of probe uptake, its dependence on transport systems and glutaminase activity. Completion of the R21will determine whether this PET glutamine tracer can discriminate triple negative breast cancers based on the glutaminolysis level, and whether clinical translation of this PET tracer is warranted for use as a predictive biomarker for therapies targeting glutamine metabolism.

Public health relevance
PUBLIC HEALTH RELEVANCE: Triple negative breast cancer is the most aggressive form of breast cancer. Because it does not have high levels of estrogen, progesterone receptors and HER-2 receptor, TNBC is resistant to the most successful treatment modalities of breast cancer, i.e., endocrine therapy and HER2-targeted therapy. Therefore, treatment of TNBC is a clinical challenge. Recent studies have found that some forms of the triple negative breast cancer are addicted to glutamine, an amino acid, for their survival and growth. Therefore, blocking the glutamine utilization pathway may provide a better treatment for such cancers. In order to identify glutamine-avid breast cancer phenotype by non-invasive imaging method, we have developed a positron emission tomography (PET) tracer. In this proposal, we will test the utility of this imaging probe against a panel of human triple negative breast cancer lines encompassing a wide range of preference for glutamine utilization. We will also determine if this probe is suitable for predicting therapies that target cancer cell's glutamine metabolism. Completion of this grant will pave the way for further development of this imaging probe for clinical translation.